High-Throughput Screen for the Oncoprotein MYC

ABSTRACT
MYC is a key transcriptional regulator involved in cellular proliferation and has established roles in transcriptional
elongation and initiation, microRNA regulation, apoptosis, and pluripotency. More importantly, MYC has been
directly implicated in over 50% of human cancers and is recognized as a general hallmark of cancer initiation
and maintenance. Despite this prevalence, there are few functional chemical probes for MYC and no
therapeutics that target it. We have discovered a compound, KJ-Pyr-9, that binds to MYC with high potency and
specificity, downregulates the transcriptional activities of MYC and, most importantly, is the first MYC ligand that
shows efficacy in vivo. However, while SAR efforts were able to improve the pharmacokinetic and
pharmacodynamic properties of the scaffold, it remains insufficient for therapeutic use. This endeavor did yield
several valuable probes, one of which, RSH470, exhibits an increase in fluorescence in the presence of MYC.
HDX-MS experiment revealed that RSH470 binds a novel site in the critical bHLH-LZ motif of MYC. Excitingly,
modeling and single amino acids mutations of the site have validated this finding and provided a structural
explanation of the inhibitor mechanism.
Utilizing RSH470, we have developed the first fluorescence-based HTS screening competition assay that
specifically identifies MYC inhibitors and does not require protein modification, DNA binding, or the
complimentary dimer partner MAX. Furthermore, it is simple, inexpensive, and free of proprietary restrictions that
limit available HTS assays for MYC. The effectiveness of this assay has been validated by established orthogonal
methods (BLI, Bio-FET, SPR) and cellular oncogenic transformation experiments. Furthermore, structurally
distinct compounds, with specific cellular activity, have been discovered by pilot screens performed on both
Scripps Research campuses. In this proposal, we present a strategy to screen of the entire >665,000 Scripps
Drug Discovery Library (SDDL) to identify novel MYC inhibitor scaffolds. A secondary HTS with and without MYC
will determine whether hit activity is MYC dependent. Hits selected by a medicinal chemist will then be validated
by bio-layer interferometry (BLI), surface plasmon resonance (SPR), and field-effect transistor analysis (Bio-
FET). Cellular potency and MYC specificity will be established through oncogenic transformation assays with
orthogonal oncogenes as well as with inhibitor resistant MYC mutants cell lines. The pharmacokinetics properties
of leads compounds will be assessed in vitro before their final evaluation in an established xenograft model. This
research program will produce a set of precisely characterized chemical leads with a strong correlation between
in vitro and in vivo efficacy. Not only will these compounds be beneficial in the study MYC functions, but they will
may lead to a therapeutic strategy for MYC driven cancers.

Public health relevance
NARRATIVE MYC is a pivotal transcription factor involved in cellular proliferation that affects a plethora of cell activities, however, its disordered nature and complex biology have made it difficult to study. We have developed a novel 1538-well fluorescence-based high throughput assay specific for identifying MYC inhibitors. Utilizing this assay, we will screen the entire >665,000 Scripps Drug Discovery Library (SDDL) and validate hits to identify inhibitor scaffolds with the potential to become new probes and therapeutics.